A Massive Library of AAVs to Target Transcriptionally-Defined Primate Cell Types

Here we will identify nonhuman primate (NHP) neuron types and build an extensive toolbox of vectors for circuit-
based neuroscience studies. NHPs share substantial neuroanatomical, genetic, and behavioral homology with
humans, and therefore they are indispensable for investigating the neural circuit basis of cognition and devising
therapies to treat neurological and psychiatric disorders. Despite the importance of NHPs, we lack the tools to
analyze and manipulate complex circuits in the primate brain. This lack severely limits the use of genetically-
coded neuroscience tools to examine circuit specific functions and hinders development of targeted gene
therapeutics. Current methods for achieving transgenesis in small model species, such as the creation of
genetically modified strains, are prohibitively expensive in NHP and not applicable to human disease. AAVs are
the leading alternative to germline modification and selective breeding. AAVs infect adult neurons, confer stable
transgene expression, and have proven safe in gene therapy clinical trials. AAVs do not have natural cell-types
specific properties, but when altered or combined with cell type specific regulatory sequences
(enhancers/promoters) they have been able to achieve cell type-specific transgenesis. This has made possible,
for example, our previous optogenetic investigation of midbrain dopamine neurons for learning and decision
making. However, before AAV-mediated gene delivery can be generalized to circuits across the brain and for
multiple behavioral functions, we must create currently lacking vectors and promoters that permit efficient and
specific gene delivery to all required cell types. Here, we will combine single-cell RNA-Seq (scRNA-Seq) with
high-throughput screening of engineered adeno-associated viruses (AAVs) to create a complete toolbox of viral
vectors and promoters enabling minimally invasive monitoring and manipulation of neurons in NHP brain. We
have devised a transdisciplinary approach to classify individual neurons according to their gene expression
profile and simultaneously screen for adeno-associated virus (AAV) vectors (capsids and regulatory sequences)
capable of specific and efficient transgene delivery to classified neurons. First, we will synthesize massive
libraries of mutated AAV vectors and synthetic promoters, in which each variant is paired with a unique DNA
barcode. We will then scRNA-Seq to capture the transcriptome for each cell and quantify the AAV and promoter-
specific barcodes in every cell’s expression profile. Preliminary experiments in Rhesus monkeys have fully
validated and demonstrated the promise of this innovative approach. The outcomes of our Specific Aims will
include (1) an inventory of cell types in the retina, prefrontal cortex, primary motor cortex, and striatum, (2) cell
type-specific AAVs and promoters targeting all defined cell types, (3) AAVs with broad tropisms, (4) a publicly
available dataset of transcription profiles for millions of NHP brain cells, (5) an updated and comprehensive
Rhesus macaque reference genome, and (6) anatomical, physiological, and functional validation of cell type-
specific circuits tools and their function in the NHP brain.

Public health relevance
Nonhuman primates (NHPs) are critical for investigating the neural basis of cognition and mechanisms of diseases. However, we lack the tools to monitor and manipulate cell type-specific neural circuits in NHPs. Here, we will use an innovative approach to simultaneously classify cell types and create a genetic toolbox to manipulate NHP neural circuits.